Smartphone-based POC Testing for HIV Using Glowstick Chemistry

Effective testing for HIV allows for detection of acute infections (new and rebound), appropriate
antiretroviral treatment, suppression of viral load, and interruption of transmission. However, early
detection of infection or regular self-monitoring at point-of-need or at home remains a challenge. Lateral
flow assays are a well-established, inexpensive point-of-need diagnostic method, and commonly are
favored when applicable because of their ease of use and low cost. Where they most commonly fall
short is in analytical sensitivity, notably in antigen-detection diagnostics for infectious diseases. Our
goal is to develop radically-improved LFAs by implementing the inexpensive, shelf-stable
chemi-excitation chemistry of glow sticks in a point-of-care format to excite fluors without light or optical
filters. Our preliminary results suggest this chemistry enables LFAs with greatly improved limits of
detection (very low pg/mL), using a standard smartphone with a $2 adaptor and no sophisticated optical
components. Our central hypothesis is that our novel, reagent-optimized chemi-excited lateral flow
assay technology integrated with a storage-stable reagent cartridge and readable with a smartphone
will lead to a new, widely-useful and potentially very-superior class of highly-sensitive lateral flow
assays. We will test this hypothesis through 5 specific aims: (1) Development of a highly-sensitive and
easily-usable lateral flow assay for HIV p24 in human blood, including development of novel
avidity-enhanced dual-fibronectin-domain binders, (2) Immune complex dissociation (ICD) for
rebound/breakthrough HIV diagnosis, (3) Testing with 300 negative and archived-positive human
samples from diverse cohorts, (4) To evaluate clinical performance using fresh samples from patients
and usability with a diverse population of subjects at high risk of HIV infection/rebound (R33 Phase), (5)
Easier usability by more people, quality assurance for test items (R33 Phase).

Public health relevance
This proposal aims to advance a new platform for high-sensitivity, point-of-care lateral flow assays to allow users to test themselves for HIV infection and rebound. Accurate, frequent HIV self-testing can facilitate early detection of HIV infection and rebound, allowing early treatment and decreasing transmission.